Mitochondrial resilience mechanisms of extremophile brine shrimp Artemia

Project Summary/Abstract
Mitochondrial dysfunction is the main mechanism contributing to cell death and tissue damage in cerebral
ischemia-reperfusion injury (I/R). Calcium-induced mitochondrial swelling, uncoupling of respiration, and cell
death occur in mammals under hypoxic conditions of I/R. These changes are due to the activation of the
mitochondrial megachannel also known as the mitochondrial permeability transition pore (mPTP). Remarkably,
the embryos of the mysterious organism, brine shrimp Artemia franciscana, tolerate anoxic conditions for several
years and were reported to lack hypoxia and Ca2+-activated mPTP opening. mPTP was at the center of scientific
research for several decades and it still remains one of the most mysterious phenomena in biology today due to
the lack of information about its exact molecular composition, structure, and regulatory mechanisms. Recently,
mammalian ATP synthase was shown to undergo calcium-induced conformational changes to form an
uncoupling channel with the biophysical properties of mPTP. In this proposal, we will use single-particle cryo-
electron microscopy (cryo-EM) to identify the high-resolution structure and activation/inactivation mechanisms
of Artemia franciscana ATP synthase. These studies will reveal the distinct structural features of Artemia ATP
synthase that prevent the Ca2+ and hypoxia-induced mitochondrial dysfunction and cell death in this organism.
Successful completion of this proposal will help to unlock the development of specific and potent therapeutic
compounds targeting mammalian ATP synthase leak channel for treating I/R injury and other mPTP-related
diseases.

Public health relevance
Project Narrative Mitochondrial ATP synthase houses a leak channel that is activated during ischemia/reperfusion (I/R) injury. This project will investigate the single-particle cryo-EM structure of Artemia franciscana ATP synthase, a mysterious organism that tolerates profound calcium concentrations and survives anoxic conditions for years. Successful completion of this project will reveal distinct structural features of ATP synthase that enable brine shrimp to resist extreme anoxic conditions and will unlock the development of new therapeutics for treating I/R injuries.